Transition from Acute to Chronic Pain After Thoracic Surgery

Project Summary/Abstract
Increasing the racial/ethnic diversity of participants in clinical pain research and including diverse partners in
the design and conduct of research are intertwined goals that are essential to increasing the acceptability,
feasibility, rigor, and relevance of pain research. This proposed administrative supplement to the parent
Multisite Clinical Center (MCC) for the Acute to Chronic Pain Signatures Program (A2CPS) at the University of
Michigan will support a robust effort to enhance patient and other community engagement, particularly that of
underrepresented minorities, and to implement a sustained outreach effort to under-resourced Black and
Hispanic communities in and around Detroit, Michigan. The goal of the A2CPS consortium is to develop
biological markers and groupings of patient characteristics that predict the development of chronic pain after
surgery, as well as well as resilience to chronic pain development. The biological markers to be studied include
patient questionnaires (e.g., pain, mood, function), brain imaging, experimental pain testing, and blood markers
(e.g., genetics). The study assesses patients before surgery and through one year after total knee replacement
or thoracic surgery. Supplement Aim 1 is to hire a full-time Community Research Facilitator (CRF) who will
conduct outreach in the Detroit areas and affiliated groups within the Henry Ford Health System and Wayne
State University. The CRF will have experience as a community health worker or similar role; that is, they will
possess deep knowledge of local resources and support a sustainable partnership between researchers and
diverse communities. The CRF will lead outreach efforts in predominantly Black and Hispanic communities in
the Detroit area to boost study recruitment efforts and increase cohort diversity; facilitate bidirectional
communication and knowledge transmission between the study team and community partners; and help
enrolled participants navigate the challenges of participating in clinical research, thereby enhancing retention.
Supplement Aim 2 is to partner with an existing Community Advisory Board, which includes people living with
pain who are diverse in terms of race/ethnicity, age, gender, and rural/urban location; as well as other advisors
including providers, clinicians, and pain researchers. This group will review study materials and processes and
give feedback on changes needed to enhance recruitment and retention of underrepresented populations.
Supplement Aim 3 will increase the research staff within the Henry Ford Detroit research and Wayne State
University teams to better staff the surgery clinics with more diverse patients and facilitate navigation of and
comfort with the in-person study visits. Finally, Supplement Aim 4 will support all research staff with direct
patient contact at our MCC to do the Faster Together training from Coursera focused on unconscious bias and
training in recruitment of underrepresented minority cohorts. The additional infrastructure afforded by this
supplement will facilitate getting input from diverse patients for new studies as they are being planned,
recruiting more diverse populations into ongoing studies, and disseminating findings to communities.

Public health relevance
Project Narrative The Multisite Clinical Center (MCC) at the University of Michigan is recruiting participants undergoing surgery for the Acute to Chronic Pain Signatures Program (A2CPS) to understand predictors of chronic pain after surgery. The goals of the supplement are to increase patient and other community engagement and to increase the racial/ethnic diversity of the study sample by improving outreach to underrepresented communities of color. Specifically, one Community Research Facilitator will be hired to conduct outreach, education, and recruitment activities within communities of color; additional staff will be hired for recruitment sites in the Detroit area; and study staff will receive formal training in unconscious bias and recruitment of diverse cohorts.